Translational Research Technologies Core

The Northern New England region is among the most rural in the U.S. It has competent investigators with
complementary expertise in biomedical research, who place a priority on collaborative team science and
translational research. However, one challenge is limited access to consolidated state-of-the-art and rapidly
advancing research resources, education, and technologies. The NNE-CTR now provides innovative and
integrated shared technical resources at partner institutions to cost-effectively support approaches with
education and training for optimal use by investigators and trainees in academic medical centers, practice-
based research networks (PBRNs), and industry throughout the region. We have consolidated strategic core
facilities by leveraging expertise in genomic/epigenomic, proteomic, lipidomic, and imaging technologies with
emphasis towards molecular diagnostics/precision medicine. Building upon our success, the goals of the
Translational Research and Technologies Core (TRTC) are to provide investigators with support for research
based on genomics, proteomics, lipidomics, cell and tissue analyses, molecular diagnostics and novel mouse
models for preclinical studies. Our secondary goal is to advance collaborative partnerships among scientists,
behaviorists, and physician investigators to foster discoveries and support the career development of
biomedical researchers with an emphasis on diversity, equity, and inclusion. Coordinating with the Community
Engagement and Outreach Core, the TRTC will expand educational efforts to facilitate bidirectional
communication and to foster collaborations and discovery in translational and clinical research. This research
infrastructure, with expanded faculty development in translational and clinical research, will also strengthen the
interactions and engagement with the NNE-PBRN and other clinician investigators to support mechanistic and
clinical investigations of cancer, cardiovascular disease, substance abuse and other diseases prevalent in the
northern New England rural population. Furthermore, the TRTC will build upon established IDeA Networks of
Biomedical Research Excellence (INBRE) programs and multiple Centers of Biomedical Research Excellence
(COBRE), to effectively leverage resources established by these programs for the enhancement of young and
established investigators. A singular important impact of the TRTC to the region was exemplified by its
unparalleled support for rapid and reliable Covid-19 testing using a single-step preparation for PCR analysis. It
is also currently supporting the development of genomic and cellular imaging-based diagnostics for future
public health challenges. TRTC will also support Department of Health initiatives in partnering states and
private sector endeavors that likely will require molecular diagnostics. In summary, the TRTC, by integrating
unique and essential biomedical research expertise, technologies, and services, will enhance research
capacity, credential research programs, and increase the competitiveness of investigators in the region for the
benefit of northern New England institutions and the people they serve.